Multifidelity and multiscale modeling of the spleen function in sickle cell disease with in vitro, ex vivo and in vivo validations

Project Summary
The spleen plays a key role in the human immune system but also clears senescent red blood cells (RBC) from
the circulation and those altered by acquired or inherited diseases. In patients with sickle cell disease (SCD), the
spleen is one of the first targets of pathogenic processes and a potential protector against major complications.
Under hypoxic conditions, mutated sickle hemoglobin (HbS) polymerizes to fibers which increase both the
stiffness and adhesion of RBC. Splenic filtration of altered RBC prone to sickling (a process that cannot be
directly observed in human subjects) contributes to anemia and likely triggers acute splenic sequestration crises
(ASSC). On the other hand, it potentially prevents complications associated with intravascular sickling. Self-
amplified blockade of vessels with sickled RBCs is indeed a hallmark of vaso-occlusive crises, acute chest
syndrome, and acute hepatic crises, that severely impact the life quality and expectancy of patients with SCD.
We propose to formulate and validate a new predictive modeling framework for how the spleen filters altered
RBC in SCD by synergistically integrating in silico, in vitro, ex vivo and in vivo data using multifidelity-based
neural networks (NN). This will deliver predictive models that can continuously learn when new data become
available, a paradigm shift in biomedical modeling. We will develop multiscale/multifidelity computational models
(and corresponding NN implementations) that link sub-cellular, cellular, and vessel level phenomena spanning
across four orders of magnitude in spatio-temporal scales. This scale coupling will be accomplished using a
molecular dynamics/dissipative particle dynamics (MD/DPD) framework. We will validate these predictive
computational models by data from in vitro and ex vivo experiments, and RBC quantitative features collected in
SCD patients. Specifically, we will use three new spleen-on-a-chip microfluidic devices with oxygen control and
the unique human spleen perfusion setup of our foreign partner, with the following aims: Aim 1: Develop and
validate a splenic inter-endothelial slit filtration model; Aim 2: Develop new models of RBC macrophage adhesion
and of phagocytosis in the spleen; Aim 3: Perform Spleen-on-a-Chip experiments and validation; Aim 4: Validate
the predictive framework based on RBC samples from patients.
Realization of our four Specific Aims will significantly increase our understanding of the complex pathogenic and
protective roles of the spleen in SCD. Feeding our new multifidelity neural networks with morphological and
functional measures of RBC circulating in SCD patients will lead to models for residual spleen function in SCD,
which should help predict the risk of acute splenic sequestration crises, and guide optimal timing for Stem Cell
Transplantation or Gene Therapy. The new paradigm in using deep learning tools to integrate data from different
sources will be applicable to modeling many other blood diseases.

Public health relevance
Project Narrative In patients with sickle cell disease (SCD), the spleen is the target of early pathogenic processes and a potential protector against major complications. We will formulate and validate predictive multiscale models for red blood cell (RBC) filtration by the spleen based on new deep learning neural networks fed with data from simulations, experiments using new spleen-mimetic microfluidics, and RBC quantitative features from ex vivo perfusion of human spleens and from SCD patients. These models will be used to predict acute splenic sequestrations crises and guide treatment decisions in patients with SCD.